Dental Research Intensive Program for Undergradate Students

______________________________________________________________________________________________
Summary
This application will establish an undergraduate summer research program that focus on dental research.
The goal of this program is to provide courses for research skill development, gain exposure to research on
dental/oral related research that will enhance the ability and confidence to investigate oral/dental related
research projects and build a pipeline for dedicated dental school students. Building on our longstanding
institutional research training experience and based on our excellent outcome measures, we are confident
that our trainees will be highly successful in getting a meaningful research experience that will keep them
interested in dental profession including dental research and/or DDS programs. The focus of this summer
research program will be to develop and sustain this training program that will provide summer research that
involves a didactic and hand-on 12 week research program for undergraduate students, followed by
summarizing and publish the project through the CATs program. We remain devoted to train a cadre of
highly skilled, interactive undergraduate students (including from underrepresentative minority populations)
who can successfully address the new opportunities in dentistry and become a part of the future academic
faculty in US dental schools. There is currently an estimated need for more than 400 dental faculty and
clinician-scientists to maintain the high quality of dental education and research at US Dental Schools. A
pivotal point in the development of dental scientists is the decision to pursue research training early on and
keep building on this experience. This is a compelling predictor of whether an individual will stay in
academics or move into private practice after graduating from the dental school. Through this training
program we hope to address the critical need for an established and structured pathway at UT dental school
that develops research competencies of these early career students (future dentists), especially those that
aspire to leading academic research careers. We are confident that this exceptional multi-interdisciplinary
program and training environment will improve the next generation of dentist. Highly motivated and
dedicated students will be selected for research training and will participate in a series of core courses and
experiences that are integrated with programs across the Dental School and the campus at large.
Importantly, sponsored activities identified here will strongly promote collaboration, and networking among
all trainees and get them excited about that will provide future clinicians/scientist that are interested in
academic research. In addition, by formally developing, a tracking and 360 evaluation plans will
continuously improve our training program, that will provide an optimal environment for research training of
new dental scientists.

Public health relevance
______________________________________________________________________________________________ Narrative There is a well-documented shortage of clinician scientist in US dental schools that are needed for research and improved dental treatments. Thus, building on our expertise in research training, we are confident that we will be able to train a cadre of highly skilled dental workforce who can successfully address the new opportunities in dental, oral, and craniofacial research and serve as future academic faculty in US dental schools.